DEVELOPMENT/TESTING SMALL ANIMAL IN VIVO MONITORING/SUPPORT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Develop and test new ventilation and monitoring and transport systems and also maintain existing systems. In particular, modify the 2T ventilation system to support noble gas imaging of the mouse lungs. Develop ventilation and monitoring systems for micro-PET.